PDXNet Data Commons and Coordinating Center

PROJECT SUMMARY
Patient-derived xenografts (PDXs) are a powerful model system to assess efficacy of anti-cancer agents and
understand molecular mechanisms of drug resistance. By applying agent combinations against patient-derived
models, it is possible to obtain evidence to determine the most promising combinations for advancement to
clinical testing in defined sub-populations of cancer patients. However, integration of PDX drug response with
molecular characterization data across diverse PDX collections is needed to enable this vision. A key aspect is
the need for well-managed resources for community sharing and large-scale analysis of standardized datasets
from PDXs and other patient-derived models. The Jackson Laboratory-Seven Bridges (JAX-SB) PDX Data
Commons and Coordination Center (PDCCC) has addressed this challenge for the last 5 years, uniting the
efforts of the data-generating (PDX Development and Trial Centers/PDTCs) and PDX model sharing (NCI’s
Patient-Derived Model Repository/PDMR) components of the PDX Development and Trials Centers Research
Network (PDXNet) into a cohesive, trans-Network whole. Using innovative cloud computing and bioinformatic
approaches, our PDCCC provides administrative and computational infrastructure for PDXNet to enable PDX
method standardization, model sharing, data sharing, and massive-scale data analysis. To date, we have built
the PDXNet Portal, which currently contains PDXNet model information and data resources from 334 new
models across 33 cancer types. Our PDCCC team has both facilitated and actively guided consortium
collaborative projects, leading to several major publications and 10 Cancer Therapy Evaluation Program Letters
of Intent. Here, we propose to enhance the PDXNet Portal and refine our organizational activities to address
needs clarified by the NCI and PDX communities, including: faster translation of PDX studies to clinical trials;
precise organization and sharing of multi-omic and treatment response data; and development of predictors of
clinical treatment response. Our Specific Aims are: 1) To provide robust PDCCC support for PDXNet
stakeholders through regular committees, personnel expertise, and project tools; 2) To enhance PDXNet Portal
content, functionality, and data sharing; and 3) To develop and implement strategies that accelerate PDX
translation to clinical trials. Through these Aims, we will coordinate the activities of the PDXNet to increase the
value of patient-derived cancer model treatment studies and speed the generation of clinical trials.

Public health relevance
PROJECT NARRATIVE To realize the full promise of patient-derived xenografts (PDXs) to advance precision therapies for cancer, standardized PDX procedures and coordinated sharing of PDX specimens are needed to validate results across research groups and determine which results may be robust for cancer patients. To address these needs, our PDX Data Commons and Coordination Center unifies the activities of NIH-supported PDX Development and Trial Centers and the National Cancer Institute's Patient-Derived Models Repository. Our Data Commons and Coordination Center uses innovative administrative, cloud computing and bioinformatic approaches to enable PDX method standardization, model sharing, data sharing, and massive-scale data analysis to accelerate translation of PDX studies into cancer clinical trials.